Structural inequality in employment as a pathway for gender disparities in ADRD

Project Summary
Women are more likely to develop Alzheimer's disease and related dementias (ADRD) later in life. The gender
disparity can be partially explained by sex-related biological differences and women's longer life expectancy.
The remaining portion is ascribed to structural inequalities. Building on prior research, I hypothesize that
women's unequal access to employment has contributed to their cognitive disadvantage by restricting their
ability to cognitive enrichment through the life course and other valuable employment-related resources. The
proposed Mentored Research Scientist Development Award (K01) will give me protected time and resources to
undertake additional training in social determinants of ADRD, implementing quasi-experimental analytic
methods using life course data, and survey cognitive health assessment. I will also bolster my understanding of
the physiological underpinnings of ADRD to be able to pursue an interdisciplinary research agenda. Supported
by a team of highly accomplished mentors in neuroscience, psychology, gerontology, epidemiology, and
population health, I will carry out innovative and rigorous quasi-experimental studies that approach the
question of women's labor force disadvantage implications for cognitive disparities from a life course
perspective. First, I will use the Irish TILDA cohort to examine the effects of married women's labor force
exclusion on their cognitive outcomes later in life. Second, I will use UK's ELSA data to study the effects of the
introduction of paid and protected maternity leave on British women's cognitive outcomes later in life. Finally, I
will use American HRS data to evaluate the impact of women's earlier retirement on their cognitive outcomes
later in life. The datasets selected combine high-quality social, cognitive, and health data and rich life course
histories. The skills and expertise I will gain will put me in a strong position to make major contributions to our
understanding of structural determinants of disparities in cognitive health, become an independent NIH-funded
researcher, and lay the foundation of my new research program in employment, policy, and cognitive
disparities.

Public health relevance
Project Narrative Women are more likely to develop Alzheimer’s Disease and Related Dementias (ADRD) and suffer from cognitive decline in later life. Using high-quality longitudinal data collected in Ireland, the UK, and the USA, the proposed set of studies will investigate the role of employment as an unequally distributed resource for maintaining and enhancing cognitive health. Additional training in social determinants of ADRD, quantitative analytic methods, and survey measurement of cognitive outcomes will put me in an ideal position to become a successful independent investigator that will make major contributions to health disparities and aging research.